Clinical Core

Clinical Core-Project Summary
The University of Washington (UW) Alzheimer Disease Research Center (ADRC) Clinical Core is a central
resource supporting ADRD research at the University of Washington. Advances in human genetics, pathology
and imaging technologies have revealed the biological diversity of ADRD, but how these diseases are rightly
divided for purposes of clinical research remains to be determined. The Clinical Core aims to capture aspects of
the clinical heterogeneity of ADRD, particularly cognitive and anatomic variability, and variability in resilience
(cognitive reserve) to AD, in a longitudinal observational cohort. We also continue to study genetic factors in
AD, and multimorbidity. The deep phenotyping of this cohort will facilitate interpretation of our biological studies
and investigation of the relationship of phenotype to underlying mechanisms.
The mechanisms that underlie resistance and resilience to AD also offer avenues to potential AD therapeutic
targets. Resilience is affected by medical comorbidities, social determinants of health, and socioeconomic
factors, all of which tend to be correlated. By defining resilience as a higher level of cognitive ability than would
be expected for a given burden of disease, we can operationalize resilience as the residual of the regression of
cognitive measures on measures of disease burden, and study the risk factors from this biological
perspective. We will recruit participants to the longitudinal cohort at the MCI stage, where this approach can
help stratify high- and low-resilience participants. We will include participants presenting with MCI who are
engaged in amyloid-clearing treatment. Participants with MCI are expected to evolve differing cognitive
trajectories, and to be cognitively phenotyped consistently and stably at the point of conversion to dementia.
The discoveries of this research must be relevant to all persons with memory loss, and we plan broad
recruitment across race, ethnicity, and SES status to make our observational studies broadly representative. An
important theme in our Center is bringing American Indians and Alaska Natives (AI/ANs), specifically, into
mainstream ADRD research, building on our successful outreach efforts over the last 10 years. We will
accomplish our recruitment aims in collaboration with the ORE cores which recruit individuals from the Memory
Brain Wellness Center, the LatinX community and the Urban and rural living AI/AN communities.
Our aims are to characterize a diverse longitudinal cohort, innovate and measure ADRD biomarkers, represent
a diversity of factors which influence resilience, and to contribute to long term biological evaluation of those who
are undergoing anti-amyloid or tau therapies.